Primary Immune Deficiency Treatment Consortium (PIDTC): A resource to drive scientific and clinical advances related to the treatment of inborn errors of immunity

Project Summary/Abstract
The Primary Immune Deficiency Treatment Consortium (PIDTC) was founded in 2009 to bring together
immunologists, bone marrow transplant (BMT) physicians, and cell/gene therapists to improve treatments and
outcomes for patients with inborn errors of immunity (IEI). The PIDTC has aggregated data from 49 sites across
the US and Canada to address key questions related to the treatment and outcomes of the most severe, life-
threatening IEIs including Severe Combined Immune Deficiency (SCID), Chronic Granulomatous Disease (CGD),
Wiskott- Aldrich Syndrome (WAS), and Primary Immune Regulatory Disorders (PIRD). The PIDTC database, along
with the associated tools that have been built to facilitate acquisition of detailed longitudinal data across a diverse
network of clinical sites, and the aggregate experience of the involved clinical and scientific experts, has become
an indispensable resource for research, treatment planning, and clinical care advancement within the IEI
community. We propose that the data, materials, and expertise of PIDTC now be organized and made available as
a resource to the entire IEI community with key enhancements that will empower the community to easily access
and use the PIDTC Resource, and simultaneously ensure the continued growth and sustainment of the PIDTC
Resource. We will expand the PIDTC Resource to increase its utility and improve the power to answer further
questions related to the treatment of IEI's including particular genotypes or clinical subtypes of disease. We will
consolidate and build tools and infrastructure to accelerate standardized data collection from ongoing and future
studies and trials that are contributing data to the PIDTC Resource. We will provide tools to make the PIDTC data
more readily accessible to the broader IEI community including researchers, clinical care providers, patient
advocacy groups, patients, foundations, and consortia. This expansion and transformation of the PIDTC into an
open resource will enable diverse users to take advantage of unparalleled IEI datasets to increase understanding
and develop better health outcomes for patients as well as conduct new studies with the support of the PIDTC
Resource database, expertise and infrastructure. Together, we will further propel the PIDTC's mission to study
therapeutic outcomes in IEI and improve the outcomes of patients with IEI.

Public health relevance
Project Narrative We propose that the data, materials, and expertise of PIDTC be organized and made available as a resource (the PIDTC Resource) to the entire IEI community (patients, clinicians, researchers, clinical trialists) with key enhancements to expand the utility and quality of the resource, improvements to expand data access and interpretation, and improved dissemination of results to accelerate knowledge generation for the field. We will do this by 1) expanding the PIDTC Resource to increase its utility and improve the power to answer further questions related to the treatment of IEI's including particular genotypes or clinical subtypes of disease; 2) consolidating and building tools and infrastructure to accelerate standardized data collection from ongoing and future studies and trials that are contributing data to the PIDTC Resource; and 3) providing tools to make the PIDTC data more accessible to the broader IEI community including researchers, clinical care providers, patient advocacy groups, patients, foundations, and consortia. The major impact of the proposed resource will be establishment of an organization that facilitates the open use of existing and new data, infrastructure, and study design expertise to expand achievement of evidence-based advances in the treatment of patients with IEI.